A prospective study of circulating autoantibodies and breast cancer risk in the NYU Women’s Health Study

SUMMARY
Breast cancer is the most commonly diagnosed cancer among US women, accounting for ~30% of all new
cancer cases in women. Identifying biomarkers associated with breast cancer risk may reveal new
pathophysiological mechanisms and potentially lead to improvements in risk stratification. The immune system
is known to play a critical role in cancer control, and experimental studies suggest that common autoantibodies
(AAbs) are involved in the earliest phase of immunosurveillance, i.e. elimination of transforming cells. Common
AAbs, which include both natural and acquired AAbs, are abundant in healthy individuals and have been
implicated in maintaining immune homeostasis and clearing apoptotic and cancerous cells. Therefore, varying
levels of certain common AAbs could indicate active immunosurveillance mechanisms that prevent cancer
development through antibody-mediated mechanisms. Levels of AAbs are now measurable at the omics-scale
in small volumes of serum. However, no prospective studies have searched for common AAbs associated with
risk of breast cancer. The New York University Women's Health Study (NYUWHS) is a prospective cohort study
that enrolled 14,274 women aged 35–65 years between 1985 and 1991. All women donated blood at the time
of enrollment. The cohort is well suited to discover new biomarkers of breast cancer risk because of its
biorepository, long follow-up, excellent cancer case ascertainment, and detailed data on breast cancer risk
factors. In a study involving NYUWHS healthy participants and two serum samples collected 1 year apart from
each woman, we tested for common AAbs using the HuProt human proteome microarray with >20,000 AAb
probes. We found that common AAbs are abundant in healthy women and that levels of most of the AAbs are
stable over time. Our goal is to identify a panel of circulating common AAbs that are protective against breast
cancer development. We will continue cancer case ascertainment through linkages to the Virtual Pooled Registry
Cancer Linkage System and electronic health records (EHRs), medical records review and data harmonization
to expand our data on tumor subtype and increase the representation of non-white cases in the proposed study
(Aim 1). We will conduct a prospective case–control study nested in the NYUWHS including 800 cases of
invasive breast cancer and 1-to-1 matched controls, with 300 case–control pairs in a discovery phase and 500
pairs in a validation phase (Aim 2). We will use cases of invasive breast cancer who had serum samples
collected >2 years before diagnosis. We will also identify correlates of AAbs (Aim 3). This study has the potential
to advance our understanding of the pathophysiological processes of breast cancer.

Public health relevance
Project narrative The goal of the study is to identify a panel of circulating autoantibodies that are associated with breast cancer risk in a prospective study. We expect that the investigation of autoantibodies in relation to breast cancer will discover an array of autoantibodies as new biomarkers that will provide new insights into risk assessment and underlying mechanism in breast cancer development.